Determining the spatial contexts that modulate immune cell phenotypes in colorectal cancer

PROJECT SUMMARY
Colorectal cancer is the fourth deadliest cancer in the US and the second deadliest in persons
under the age of 50, with a five-year survival rate less than 66%. Immune checkpoint inhibitors
have become the standard of care for patients with microsatellite-instability high and mismatch-
repair-deficient colorectal cancers, but these represent only ~7% of patients. Within the other
93% of patients, some respond to immune checkpoint inhibitors, but without predictive
biomarkers to identify those who will benefit, the survival benefit is not enough to justify clinical
use.
Interacting cellular communities in the tumor microenvironment comprised of cancer, immune,
and other cells can promote or restrain the antitumor immune response. These communities,
termed ecotypes, can be described by the transcriptional states of their constituent cells. Work
in other cancers has identified ecotypes that maintain functional or hypofunctional T cell states
and predict response to immunotherapy.
The central goal of this proposal is to identify spatially organized ecotypes in colorectal
cancers that govern antitumor T cell activity and predict patients’ response to immunotherapy
across all forms of colorectal cancer. This project will use a transcriptomic atlas of more than
200 colorectal cancer patients’ tumors curated from published data, including more than 170
pre-treatment samples from patients treated with immune checkpoint inhibition. A novel deep
learning algorithm designed for the proposal will be used to identify spatial ecotypes in the
colorectal cancer microenvironment from transcriptomics data.
In the long term, robust predictive markers of response to immunotherapy would expand the
population of patients eligible for immunotherapy by identifying the microsatellite-stable cancer
patients most likely to benefit. Defining these predictive markers in terms of spatially organized
multicellular communities will identify the cell-cell interactions that promote or restrain antitumor
immunity, which could ultimately identify new drug targets to augment or improve upon existing
immunotherapies.

Public health relevance
PROJECT NARRATIVE This project aims to understand how spatially organized multicellular communities in colorectal cancer promote or hinder the anti-tumor immune response. The goals are to identify molecular interactions that influence immune cell activity and to identify markers that can predict which patients will benefit from immune checkpoint inhibitors. The findings from this project could ultimately extend eligibility for immune checkpoint inhibitors to more colorectal cancer patients and identify targets for new forms of immunotherapy.